Are you REDDE? Expanding a Mobile Vessel Safety and Training Service for Northeast Fishermen

Abstract:
Commercial fishermen spend one third of their lives at sea participating in one of the most
dangerous jobs in the world. Vessel masters are required by law to keep onboard a series of
specially designed pieces of equipment to save their lives in case of an emergency. These
pieces of equipment must be maintained properly and serviced or replaced periodically. It is not
only a regulatory requirement, but also an essential function of the fishing vessel. Faulty,
expired, or missing equipment can cost fishermen days tied to the dock, thousands in lost
revenue, and in extreme cases, the ultimate price of their life. REDDE Marine is a full service
safety equipment and training start-up company with a mission to create a culture of safety in
northeast fisheries and boating. REDDE offers its clients a “Full Service Safety System” which
includes an initial vessel audit inspection followed by periodic mobile service and replacement
on all safety equipment and specialized training for operation in northeast fisheries. It is the only
full service safety company that comes to you, with proprietary software that ensures its clients
never have an expired piece of equipment. REDDE provides the training necessary to make
sure clients are comfortable and knowledgeable in any type of emergency situation. The specific
aims of our project are to: (1) Build the region’s first safety skiff capable of servicing Maine’s
remote and Island communities, (2) Provide Drill Conductor and First Aid / CPR training to 400
captains and crew annually, (3) Gather data pertinent to improving safety equipment on fishing
vessels, (4) Expand inventory of loaner survival equipment (5) Build a storage facility for vessel
and gear, and (6) Improve functionality of database with automated communications. The
overall goal of our program is to ensure that our clients never leave the dock with inadequate
gear or training. Our vision is that every fisherman in the country treats safety with the same
importance as providing for their family.

Public health relevance
Project Narrative: Commercial fishermen spend one third of their lives at sea participating in one of the most dangerous jobs in the world. REDDE Marine Safety offers its clients a “Full Service Safety System” which includes an initial vessel audit inspection followed by periodic mobile service and replacement on all safety equipment and specialized training for operation in northeast fisheries. Our company’s mission is to create a culture of safety among our region’s commercial fishermen.